Functional Genomics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
Functional Genomics and Bioinformatics (FGB) Core
The Functional Genomics and Bioinformatics (FGB) Core is housed in a designated space within the Sanford
Research Center and offers a range of molecular biology, genomics and bioinformatics services. The FGB Core
has the infrastructure, expertise, equipment, and technical capabilities to provide both standard as well as
specialized molecular and functional genomics services. The state-of-the-art equipment in the laboratory, along
with the well-trained staff enable the core to continue to provide a wide range of molecular and genomics assays,
including nucleic acid isolation and quality analysis and manipulation, quantitative real-time PCR analysis,
RNAScope based gene expression pattern analysis, transcriptomics, single cell genomic studies, chromatin
immunoprecipitation (chIP) studies, CRISPR/Cas9 mediated genome editing studies and bioinformatics
services. Many of these services interface with other core facilities at Sanford Research such as the Flow Core
for the genome editing projects, and Histology and Imaging Core for RNAScope studies. The bioinformatics
services include analysis of RNA-sequencing, ChIP-sequencing, ATAC-sequencing, and single cell RNA-
sequencing and whole exome sequencing results. We also provide network analysis as well as other customized
informatics analysis. These bioinformatics services are provided in partnership with the South Dakota State
University (SDSU) High Performance Computing Center. The FGB Core also assists with communicating and
coordinating studies between Sanford Research scientists and providers of high throughput sequencing services
such as the Sanford Prebys Burnham Medical Discovery Institute (SPBMDI) Genomics Core. The Core staff
directly interact with research investigators to provide consultations, to assist with experimental design, assay
execution and data analysis. The FGB Core also assists with preparation of manuscripts and grant proposals as
well training of students interested in learning the techniques provided by the core. These FGB Core services
have contributed extensively to publications, grant applications, and preclinical studies. The FGB core intends
to continue to serve as a provider of current and advanced genomics techniques that strengthen the independent
research programs at Sanford Research as well as at other regional Research Centers.